Engineered 3D microfluidic tubular device as multimodal, functional tissue model

Abstract: Calcium phosphate (CaP) deposition is characteristic of several life-threatening kidney and cardio-
vascular diseases; thus, understanding CaP biomineralization is essential for developing new clinical
therapies. Previous studies either analyzed extracted stones from patients or reproduced CaP deposits in
quasi-2 dimensional (D) in vitro systems. However, such approaches fail to capture real-time kinetic
information of mineralization and the 3D cellular microenvironments found in vivo – both of which are essential
for understanding CaP biomineralization. Despite extensive research, mechanisms by which crystals nucleate,
grow, and aggregate into stones are still poorly understood due to a lack of suitable bioanalytical tools that
offer dynamic control over the microenvironments. Using our novel 3D microfluidic (MF)-based workbench that
we achieved previously with unattained precision in controlling dynamic, spatiotemporal biological conditions of
in vivo tubular systems, we will elucidate the origin and mechanisms of calcium mineralization and CaP stone
formation. To recreate in vivo-like conditions, we will use an improved functional 3D-renal tubular system
(RTS) using porous membranes to examine apical↔basal transport. This transformative strategy will allow us
to evaluate/validate the contribution of dynamic microenvironmental cues (e.g., cellular regulations, microscale
hydrodynamics) in CaP stone formation. Our overall hypothesis is that the combined interplay between
tubular epithelial cells and its luminal fluid within these vivo-like RT structures would recapitulate normal and
pathophysiological biomineralization by identifying precise microenvironmental dynamic factors influencing
CaP stone formation. We will systematically evaluate the role of molecular factors (e.g., ionic supersaturation,
stone forming activators/inhibitors) and dynamic microenvironmental cues that underlie CaP stone formation.
We propose to (i) reprogram/recreate a fluidic microenvironment in improved 3D MF devices using polarized
tubular epithelia, and (ii) mimic the in vivo stone-forming conditions by regulating cellular microenvironment
(oxidative stress, inflammation, and fibrosis) within these 3D in vitro microsystems. Our rationale is that the
sequential introduction of factor(s) of stone formation within the perfused constructs will allow us to identify
currently unknown molecular bases of pathophysiological biomineralization. In Aim 1, we will validate the
functional 3D-MFs by examining the endogenous (biomolecules), exogenous (environmental) factors, and the
effects of inner lumen topological defects to determine factors regulating nucleation, growth, and dissolution of
CaP crystals. In Aim 2, we will map and characterize real time step-by-step dynamic growth patterns/rates of
crystal towards stone formation. In Aim 3, we will invoke the processes of fibrosis, inflammation, calcification,
and apoptosis at controlled times to determine the impact on CaP crystal dynamics within 3D tubular structures
in MFs. The proposed study will lead us to i) find strategies to prevent and treat calcium stone disease in
kidney and other organs; ii) gain new insights on the abnormal CaP deposition in soft tissues; and iii)
revolutionize our understanding of calcium biomineralization at the systems level, which will be useful for
clinical interventions in several diseases.

Public health relevance
Project Narrative: The prevalence of kidney stones and associated clinical condition in the United States has risen for decades. The diagnosis, treatment, high recurrence, hospitalizations, surgery, and lost work time account for over 5 billion dollars in economic burden in the United States each year. Stone formation is also associated with increased rates of chronic kidney disease and hypertension which are not sufficiently explained by obesity, a risk factor in each of these conditions. The majority (80%) of these calcium stones are found to be calcium oxalate (CaOx), with variable amounts of calcium phosphate (CaP). The proposed validation research aims to develop a new level of understanding on the mechanisms of kidney stone formation using an innovative microfluidic platform towards advancing new clinical solutions for preventing or treating nephrolithiasis and other diseases relevant to extra-skeletal calcification.